GUARDD-US Additional Recruitment

Project Summary
Using genomic variation to tailor therapeutic, preventative, and diagnostic decision-making is a
potentially transformative approach to clinical care. However, uncertainty about clinical impact
and economic value presents a critical barrier to broad adoption. The Integrated, Individualized,
Intelligent Prescribing (I3P) Clinical Trials Network includes three clinically and
sociodemographically diverse health systems to IGNITE 2: Metro General Hospital at Meharry
Medical College, Sanford Health and Vanderbilt University Medical Center (VUMC). The
Network will develop infrastructure to quickly recruit large, diverse patient populations, return
results at the time of clinical indication, and provide health care providers with understandable,
implementable guidance during the course of the trial. The first aim will develop and implement
infrastructure to efficiently conduct pragmatic clinical trials involving Genomic Medicine across
the diverse settings within I3P. The second aim proposes a randomized, pragmatic clinical trial
of multiplexed pharmacogenomics testing across the IGNITE 2 Network to establish the clinical
utility of panel testing. And finally, I3P will develop and implement an IGNITE 2 Network-wide
capability to calculate Phenotype Risk Scores across health system populations to efficiently
identify and intervene on patients likely to have a genomic diagnosis. All of the institutions
within the I3P Network will leverage their strong record of collaboration within IGNITE 1 and
other NIH funded consortia to accomplish these aims.

Public health relevance
Project Narrative The evidence base supporting the clinical and economic value of genetic testing is incomplete and an impediment to broader adoption of this technology. The Integrated, Individualized, and Intelligent Prescribing (I3P) Clinical Trials Network will conduct pragmatic clinical trials as part of IGNITE 2 to test key research questions regarding the effectiveness of using genetic information to tailor prescribing, diagnosis, or preventative care. The I3P Network will also develop infrastructure and new capabilities to increase the efficiency and reach of any pragmatic clinical trial conducted within IGNITE 2.